Interoception and Obesogenic Eating Behaviors in Children

PROJECT SUMMARY/ABSTRACT
Obesity is a key risk factor for several types of cancer. Development of healthy weight and eating behaviors
during childhood has the potential to reduce cancer risk in adulthood. Preadolescence is a key risk period, as
children become more independent in their food choices and eating behaviors. Non-homeostatic eating, i.e.,
eating that occurs in response to external cues rather than physiological need, increases in preadolescence
and is a risk factor for obesity. Individual differences in interoception, the process by which internal bodily
states, like hunger and fullness, are sensed, integrated, interpreted, and regulated, may contribute to
propensity for non-homeostatic eating. A number of studies have found that children with obesity have poorer
interoceptive awareness than children without obesity, but studies examining the relationship between
interoception and eating behavior are lacking. Furthermore, it is unknown if obesity-related impairments in
interoception are due to inadequate physiological signaling of internal states (‘bottom up’ processes) and/or
impaired cognitive interpretation of these signals (‘top down’ regulation). Levels of ghrelin, a hunger hormone
produced by the stomach, typically peak just before a meal and decline following food intake; however, this
response to food intake is blunted in individuals with obesity. Altered ghrelin secretion in response to a meal
may result in incorrect interoceptive signaling to the brain. The primary goals of this R21 are to better
understand how individual differences in multiple features of interoception contribute to objectively-measured
non-homeostatic eating in children. To do this, children age 7-10 years with or without obesity (n=60) will
complete a series of questionnaire and laboratory-based behavioral measures of interoception. On a separate
occasion, children will consume an ad libitum meal followed by a non-homeostatic eating task (Eating in the
Absence of Hunger [EAH]), providing saliva samples for measurement of ghrelin and leptin before, during, and
after these tasks. For Aim 1, we will determine if interoception is associated with kcal intake in the EAH task;
we hypothesize interoception will be inversely associated with intake. For Aim 2, we will examine salivary
ghrelin and leptin as interoceptive signals of hunger/satiety; we hypothesize that children with greater
postprandial ghrelin suppression will have better interoceptive awareness and will eat less in the EAH task,
and that elevated leptin will attenuate the relationship between ghrelin suppression and interoception. For Aim
3 (Exploratory) we will use cluster analysis identify profiles of interoception based on global and system-
specific (e.g., cardiac, gastric) interoception, and then examine differences in eating behavior, executive
function, and weight between clusters. This project will extend our understanding of the drivers of non-
homeostatic eating and reveal how interoceptive awareness impacts food intake, setting the foundation for
intervention strategies tailored for children based on individual differences in interoceptive function.

Public health relevance
PROJECT NARRATIVE Children with obesity often have poorer interoceptive awareness, the ability to sense, interpret, and regulate internal bodily states like hunger. This project will examine how individual differences in interoceptive awareness relate to children’s overeating behaviors (e.g., eating in the absence of hunger), and whether dysregulation of appetitive hormones ghrelin and leptin contribute to poorer interoceptive awareness. Findings will inform whether interventions targeting interoceptive awareness may be helpful for prevention of obesity and related chronic diseases.